General Brain Arousal and Risk for Eating Disorder

The prepubertal gonadal hormone surge that primes the rapid social and emotional development of
adolescence has specific influences on female brains that may account for the accelerated risk for disordered
eating and development of binge eating in girls relative to boys. We propose to test a model of sex differences
in the risk for binge eating in early adolescence that emphasizes the differential influence of gonadal hormone
status on the development of functional brain networks in girls relative to boys to account for the enhanced risk
during this vulnerable period. The model leverages general brain arousal theory to predict the effect of gonadal
hormones on functional brain networks, and builds on theoretical work by the MPI, seminal work by Dr. Kelly
Klump and colleagues on moderated genetic risks for disordered eating in twin studies, and the pioneering
work of Dr. Donald Pfaff and colleagues on the activating effects of gonadal hormones.
The specific aims of this R01 project are two-fold: 1) to test for sex differences in the mediation of
binge eating risk by gonadal hormonal influences on brain networks for arousal, reward processing, emotional
salience, and inhibitory control at baseline and longitudinally over 2-year follow-up; and 2) to develop a
computational model of general brain arousal to explain sex differences in the risk for binge eating in early
adolescence. The central hypotheses are that (i) gonadal hormone status will predict the developmental
status of functional brain networks for arousal, reward processing, emotional salience, and inhibitory control
longitudinally in girls but not boys; (ii) these neuroendocrine interactions will mediate the risk for binge eating
longitudinally in girls but not boys; and (iii) gonadal hormone status will predict covariation between these brain
networks in girls but not boys, suggesting a sexually dimorphic mechanism for gonadal hormones to influence
a range of behaviors characterized by altered responses to salient, rewarding, and stressful environmental
cues. The large set of clinical, endocrine, and functional magnetic resonance imaging (fMRI) data collected for
the Adolescent Brain Cognitive Development (ABCD) study at baseline and follow-up presents an ideal
mechanism to test this model of sex differences in risk for binge eating during the critical developmental period
in early puberty when gonadal hormone levels surge and maladaptive eating behaviors first emerge.
These aims have direct

Public health relevance
The prepubertal hormonal surge that primes the rapid social and emotional development of adolescence may accelerate risk for disordered eating and the development of binge eating, particularly among girls. This project will test a model of sex differences in risk for binge eating that positions differential gonadal hormone influences on the development of functional brain networks in girls relative to boys as a key determinant of accelerated risk for disordered eating during this vulnerable period. Validation of this model would constitute important progress in delineating the neuroendocrine basis of sex differences in eating disorder risk and could have wide applicability to other behavioral and psychosocial problems characterized by altered responses to natural environmental cues (food, substances of abuse, etc.).